Cardiotoxicity of catecholamine metabolism by monoamine oxidase with obesity

Project Summary
Monoamine oxidase (MAO) is a mitochondria-localized enzyme that metabolizes catecholamines via oxidative
deamination to produce H2O2, NH4+, and catecholaldehydes, each of which may individually induce toxicity
and/or lead to secondary metabolic effects in the cell. Our lab and others have demonstrated the
pathophysiological significance of MAO in heart with experimental and clinical models of pressure overload,
arrhythmia, and diabetes. Obesity and insulin resistance are widespread and growing metabolic disorders known
to be linked to cardiomyopathy, and previous work from our lab has shown that MAO activity increases while
catecholaldehyde-detoxifying enzyme decreases in the heart with these disorders, leading to a buildup of
reactive metabolites causing derangements in mitochondrial ATP production. We have also shown that
catecholaldehydes stimulate pro-inflammatory and pro-fibrotic signaling in the heart, and that the histidyl
dipeptide carnosine mitigates these effects by neutralizing these reactive molecules. Together, this suggests a
significant role for MAO in obesity/insulin resistance-associated cardiomyopathy, although the targets and
mechanisms driving the metabolite toxicity are unknown, largely due to the highly reactive nature of these
molecules and difficulties associated with their detection. These knowledge gaps must be addressed in order for
therapeutic development to proceed. In this project I will test the hypothesis that all 3 of MAO’s reactive
metabolites (i.e., H2O2, NH4+, and catecholaldehydes) contribute individually to mitochondrial abnormalities and
electromechanical dysfunction in heart with diet-induced obesity, and reducing their production in
cardiomyocytes via genetic (i.e., cardiomyocyte-specific MAO-A deficiency, cMAO-Adef) and pharmacological
approaches (i.e., oral carnosine therapy) will be cardioprotective. As part of my dissertation project I have
recently developed a sensitive LC-MS/MS method to detect and quantify catecholaldehyde-carnosine adducts
in biological material, which will be used as a quantitative biomarker to track effectiveness of MAO inhibition and
carnosine efficacy in the mouse models employed. I will accomplish the goals of this research through three
specific aims using wild-type and cMAO-Adef mice on normal chow and high fat, high sucrose diet. In Aim 1, I
will determine the extent to which cardiomyocyte MAO-A deficiency mitigates derangements in myocardial
structure, tissue composition and function with obesity/insulin-resistance. In Aim 2, I will determine the
mechanisms by which MAO metabolites contributes to mitochondrial abnormalities in the heart with
obesity/insulin-resistance. In Aim 3, I will interrogate molecular targets of catecholaldehydes and MAO-
dependent oxidative damage in the hearts of obese/insulin-resistant mice. To accomplish these goals, I will work
with an interdisciplinary team of toxicologists and cardiovascular physiologists and the core facilities at the
University of Iowa. It is anticipated that my project will advance the fields of toxicology and molecular cardiology,
and illustrate pathways by which MAO and its metabolites are viable drug targets in the heart with obesity.

Public health relevance
Project Narrative Neurotransmitters such as dopamine and norepinephrine are metabolized in heart cells by monoamine oxidase (MAO) and over time this reaction can become toxic and contribute to heart failure. In this project we will examine the role of MAO in causing heart problems in obese mice, and uncover molecular processes involved. The goal of this research is to improve our understanding of obesity-associated cardiovascular disease and identify the potential of MAO and its downstream metabolites as new therapeutic targets.